LONG-CHAIN ACYLCARNITINES &ARRHYTHMOGENESIS

Much evidence supports the hypothesis that accumulation of noxious metabolites in the ischemic heart contributes to electrical instability and sudden death following myocardial infarction. Recent evidence strongly suggests that long-chain acylcarnitines accumulated in the sarcolemma of hypoxic myocytes and play a significant role in the genesis of arrhythmias. The objective of the proposed work is to further elucidate the role of long-chain acylcarnitines in arrythmogenesis. This study will utilize a combination of biochemical and intracellular recording techniques in a cultrued rat neonatal myocyte preparation subjected to hypoxic perfusion. Experiments are planned to identify the biochemcial mechanisms responsible for long-chain acylcarnitine accumulation and to delineate factors that modulate their metabolism. Common anti-arrhythmic drugs will be tested for their ability to inhibit long-chain acylarnitine elevation. Preferential extraction of long-chain acylcarnitines from sarcolemma will be attempted and cells will be monitored electrophysiologically. The ultimate goal is to develop methods that inhibit elevation or prevent the effects of long-chain acylcarnitines in hypoxic tissue and offer promise for protection of the ischemic heart against potentially fatal arrhythmias.